ORAL NICTOTINIC ACID FOR TREATMENT OF LESCH NYHAN PATIENTS

Evaluate the possible therapeutic benefit of oral doses of nicotinic acid for reducing the high intracellular content of phosphoribosyl pyrophosphate found in patients with Lesch-Nyhan disease and thereby ameliorate the clinical features of the disease.